A Biobehavioral Research Training Grant

Project Abstract:
This is an application for competitive renewal of an institutional training grant that to date has trained 89
postdoctoral fellows for careers in preclinical, clinical and translational research in psychiatric disorders.
Physician trainees are eligible if they have completed the PGY 3 year of psychiatry training or PGY 4 year of
neurology; psychology trainees are eligible if they have completed an APA approved clinical internship.
Fellows work with a mentor who is a member of the Stanford University faculty for a period of two years on
projects related to the clinical/biological (including brain imaging) phenomenology, basic neuroscience
(including optogenetics and organoids), and translational treatment outcomes of psychiatric disorders. The
Program includes seminars in research methodology, clinical research design and statistical analysis.
Additionally, all fellows are required to take a course focused on ethics in medical research and are
encouraged to take the course in reproducibility of evidence. They have access to a wide array of elective
courses and workshops offered at Stanford University. Mentorship emphasizes the development of an
independent career. Fellows are expected to design and conduct their own research projects and are
mentored in applying for funding to support their research post fellowship. An Executive Committee provides
program oversight including continual review trainees' progress towards their individual goals and the of the
training program.
The Program is now in its 29th year. Fifty postgraduate trainees (MDs, MD/PhDs and PhDs) have been in the
program in the past 15 years. Graduating fellows have been successful in obtaining faculty positions around
the US and Canada (e.g., Stanford University, Weil-Cornell, Medical College, Yale University, UCSF, U.
Pennsylvania, U Texas at Austin, Baylor, etc.) A strong majority continue to be involved in mental health
research and have obtained funding to support their research, including NIH Career Development Awards:
R01's; NIMH Director Awards (e.g., BRAINS and Pioneer Awards), Simons Foundation Awards, Welcome
Trust Awards, NARSAD Young Investigator Awards, Klingenstein Foundation Awards, and other foundation
grants. Building on the success of our program in attaining its goals, we aim to continue to train promising
clinically trained fellows to become independent mental health researchers working to advance mental health
care.

Public health relevance
Project Narrative: Training mental health researchers to conduct basic and translational research is important for advancing our understanding and treatment of psychiatric disorders and for reducing the burden of these disorders on patients and their families. Increasing the ranks of outstanding mental health researchers can also aid in prevention of mental disorders. The goal of the Biobehavioral Research Training Program is to help trainees' becoming independent researchers by developing basic, clinical, and translational research skills that are needed for conducting research that can enhance the effectiveness treatment of mental health disorders as well as hopefully preventing their onset and progression.